INVESTIGATING THE MOLECULAR MECHANISMS OF DIFFERENTIATION FAILURE IN NF2 MUTANT NEUROEPITHELIAL STEM CELLS

ABSTRACT
My long-term career goal is to develop more effective treatments for brain and spinal cord tumors in children
and young adults with cancer predisposition syndromes. Spinal ependymoma (SP-EPN) is a molecularly distinct
tumor that arises predominantly in the upper spinal cord. Most SP-EPN have biallelic genetic perturbations
affecting the NF2 gene, and patients with NF2-associated schwannomatosis are predisposed to SP-EPN
development. There is currently no effective medical therapy for SP-EPN. Surgical resection of late-stage
symptomatic lesions is associated with high morbidity and mortality. There is a critical need to identify the
molecular mechanisms underpinning pre-neoplastic lesions to halt progression in NF2 patients at an early stage.
In our preliminary studies, we leveraged a unique spinal neuroepithelial stem (NES) cell model to show failure
of differentiation at the radial-glia cell stage in NF2 knockout (NF2-/-) NES cells and the formation of pre-
neoplastic growths in vitro and in vivo. Further, although most of the SP-EPN tumor display ependymal cell
signatures, we identify a rare population within the tumor with radial-glia stem cell markers. The specific
objectives of this study are: (i) to identify the cellular hierarchy in NF2-/- NES cell derived preneoplastic cells
and patient-derived SP-EPN; (ii) to define the dysregulated signaling pathways in NF2-/- NES cells that fail to
differentiate and (iii) to identify activated kinase targets that may rescue this differentiation failure. We
hypothesize that derailed radial glia cells in the developing spinal cord are the source of SP-EPN formation and
that targeting the aberrant signaling pathways in these cells will be important to prevent growth. To test this
hypothesis, we will perform single cell RNA sequencing (scRNA seq) of NF2-/- NES cells during in vitro
differentiation and xenografts (Aim 1). We will compare the molecular signatures of cells in pre-neoplastic
growths with that of patient samples to validate the target pre-neoplastic cells in SP-EPN development. We will
perform bulkRNA seq and multiplexed kinase inhibitor bead affinity chromatography and mass spectrometry
(MiB/MS) to define the activated kinome profile of these pre-neoplastic cells compared to patient SP-EPN (Aim
2a) and the key signaling pathways that are disrupted in these cells. In Aim 2b we will test candidate kinase
inhibitors to test in our NF2-/- NES cell model to determine if the failure of differentiation can be rescued
pharmacologically. We expect to identify the cellular identity of NF2-/- preneoplastic cells that fail to differentiate,
and the dysregulated signaling pathways that may be governing these cells. We aim to identify novel, rational
therapeutic targets to stop the progression of tumor formation in children with NF2. To achieve research
independence, I have identified three key areas in which I need mentorship and additional experience: (1)
advanced cell engineering; (2) single cell analytics; (3) kinome profiling for drug discovery. I will accomplish this
work under the mentorship of Dr Wade Clapp, a world expert in neurofibromatosis. Ultimately, I want to become
an RO1 funded independent investigator directing a research program in brain and spinal cord tumorigenesis.

Public health relevance
Project Narrative The only treatment for late-stage symptomatic ependymoma is high-risk surgery. We have identified novel dysregulated radial-glia like cells that fail to differentiate normally in the setting of NF2 loss. This research will determine dysregulated signaling pathways in these pre-neoplastic cells to identify new drug targets.